Non-invasive brain stimulation and neurovascular mechanisms of post-stroke cognitive impairment

PROJECT SUMMARY
Stroke is the leading cause of death and long-term disability in the United States. Up to 60% of stroke
survivors develop post-stroke cognitive impairment (PSCI) in the first year after stroke. PSCI is a significant
public health problem, as it can lead to a loss of independence, reduced quality of life, and increased healthcare
costs. Despite its high prevalence, there is no established treatment for PSCI.
New and innovative treatments are needed to improve cognitive function in stroke survivors with PSCI.
Transcranial direct current stimulation (tDCS) is a non-invasive brain stimulation technique that has shown
promise in improving cognitive function in a variety of conditions, including stroke. tDCS works by delivering a
weak electrical current through the scalp. This current can modulate the activity of neurons in the brain. While
tDCS has been shown to improve cognitive function in stroke survivors, the mechanism by which this effect is
mediated remains understudied. Although most existing studies have primarily focused on the neuronal effects
of tDCS, brain stimulation has a broad effect on a variety of brain cells and several studies report that tDCS can
increase resting cerebral blood flow both in animals and healthy individuals. However, whether tDCS is capable
of modulating hemodynamic responses in PSCI is significantly understudied.
This project will investigate the potential of tDCS as a therapeutic intervention to improve neurovascular
coupling (NVC) and cognitive function in stroke survivors with PSCI. NVC is a critical mechanism that allows the
brain to match blood flow to metabolic demand. Current clinical evidence indicates that NVC impairment is
associated with PSCI.
In Aim 1, I will comprehensively evaluate NVC responses in stroke survivors with and without cognitive
impairment, and compare their NVC responses to healthy sex and age matched controls. In Aim 2, I will conduct
a prospective sham-controlled clinical trial to determine if active tDCS leads to a significant improvement of NVC
responses in stroke survivors and whether these changes are associated with improvements in cognitive
performance. This project has the potential to develop a novel and effective treatment for PSCI. By using a
multimodal approach (simultaneous fNIRS-EEG), this proposal aims to investigate a potentially reversible
mechanism of cognitive decline following stroke and contributes to the advancement of neuroscience research
in vascular cognitive impairment.

Public health relevance
PROJECT NARRATIVE: One of the devastating, yet understudied outcomes of stroke is a persistent deterioration of cognitive abilities in stroke survivors. Previous studies and my preliminary data suggest that transcranial direct current stimulation (tDCS) indicate that this non-invasive brain stimulation methodology may provide an important therapeutic approach to combat post-stroke cognitive impairment. Further, my research proposal will explore understudied mechanisms by which tDCS exerts its effect on cognitive function in stroke survivors.